Career Enhancement Program

ABSTRACT– CAREER ENCHANCEMENT PROGRAM
The DHART SPORE Career Enhancement Program (CEP) supports faculty at the Instructor and Assistant
Professor levels to engage in translational research focused on NF1/Rasopathy disorders and cancer. The
primary goal of the CEP is to advance the careers of early stage investigators who are developing innovative
research related to the goal of implementing more effective and less toxic therapies for cancers characterized
by NF1/Ras. The multi-institutional nature of this SPORE leverages a large and talented pool of early career
faculty from multiple disciplines. Each institution views the CEP as a vehicle for recruiting and advancing the
careers of early stage translational scientists. Collectively, they have committed $1.3 million to the current
award and $1.65 million to the renewal to support the Developmental Programs of the DHART SPORE (CEP
and DRP). The Specific Aims of the CEP are to: (1) support early stage investigators as they develop
innovative research programs that contribute new knowledge to NF1-related cancer research while generating
preliminary data that will allow successful future independent extramural funding; (2) provide early stage
researchers with training that will equip them with essential skills and knowledge for success as independent
investigators; and, (3) mentor early stage translational researchers through regularly scheduled one-on-one
mentor meetings and a structured Individual Development Program (IDP) to facilitate integration into the fabric
of the SPORE. The CEP has a special emphasis on supporting the recruitment of underrepresented minority
investigators (URM). The DHART SPORE will link vertically and horizontally with diversity programs at all of
the consortium institutions and ensure maximum exposure of the CEP mentorship and funding opportunities to
URM across the seven DHART SPORE sites. Further, requests for applications (RFA) will be shared with
Historically Black Colleges and Universities and professional organizations representing communities under-
represented in biomedical science. RFAs are already sent outside of the DHART SPORE sites via the
Children’s Tumor Foundation and Neurofibromatosis Therapeutic Acceleration Program. We are expanding
this recruitment effort to include the Society for Neuro-Oncology, RASopathies Network USA, the Children’s
Oncology Group. The goal is to fund two CEP proposals per year ($50,000 - $75,000/proposal). Requests for
applications will be announced twice a year via broad communications to all groups listed above to maximize
opportunities for recruitment of diverse scientists and science. CEP opportunities will also be highlighted at
professional meetings throughout the year. Applications for CEP support will be evaluated through a
competitive process with review by a Developmental Programs Steering Committee comprised of senor
scientists from the DHART SPORE with oversight and guidance from the SPORE External and Internal
Advisory Boards.

Public health relevance
PROJECT NARRATIVE – CAREER ENCHANCEMENT PROGRAM The Developmental and HyperActive Ras Tumor (DHART) SPORE Career Enhancement Program (CEP) supports faculty at the Instructor and Assistant Professor levels to engage in translational research focused on developing treatments for tumors characterized by mutations in NF1. The CEP recruits early stage investigators, with a special emphasis on recruiting underrepresented minority investigators, and provides financial and scientific support (via core expertise and facilities), and structured mentorship from SPORE scientists to accelerate CEP awardee development into independent researchers in the field of cancer biology and therapeutics related to NF1.